Integrative metabolomic characterization of ADHD and asthma comorbidity

PROJECT SUMMARY/ABSTRACT
Su H. Chu, PhD, MS is a biostatistician and molecular epidemiologist with strong and substantial commitments
to integrative omic research in respiratory and neurodevelopmental disease. Her career objective is to become
an independent investigator with expertise in developing and applying novel statistical methods and multiomic
network approaches that facilitate mechanistic understanding of the intersection of respiratory and
neurodevelopmental disease. This proposal combines Dr. Chu’s extensive training in integrative omic methods
development, along with her experience in genetic and metabolomic research, to examine the integrative
metabolomic etiology of asthma and attention-deficit/hyperactivity disorder overlap (AAO). A wealth of
epidemiological literature has revealed with remarkable consistency that asthmatic patients are at greater risk
for ADHD, and vice versa, with a number of longitudinal studies of childhood asthma indicating excess risk of
ADHD in adolescence and adulthood. However, no studies have directly interrogated the biological mechanisms
by which these conditions may be related. The central hypothesis of this proposal is that childhood asthma and
ADHD share both common and distinct dysregulated metabolic processes, some of which may have drivers that
are genetic in origin. This will be explored using existing genetic and metabolomic data from the Childhood
Asthma Management Program (CAMP), the Vitamin D Antenatal Asthma Reduction Trial (VDAART), and the
Copenhagen Prospective Studies on Asthma in Childhood 2010 (COPSAC), three large prospective cohorts of
children with extensive longitudinal phenotyping and multiple omic data types, by identifying metabolites and
metabolic profiles associated with AAO (aim 1), constructing multiomic models and features that characterize
dysregulated metabolic processes and their upstream drivers in AAO (aim 2), and validation and replication of
all findings (aim 3). As Dr. Chu completes these aims, her career development program will facilitate the
achievement of her primary training goals: 1) increase clinical understanding of ADHD and asthma diagnosis
and treatment; 2) gain a nuanced understanding of best methods for, and practical experience in, the biological
and statistical integration of genetic and metabolomic data; 3) develop skills in machine learning and integrative
network methods for multiomic analysis; 4) strengthen current areas of experience to stay on the cutting edge of
new analytic and study design techniques; and 5) enhance skills in mentorship, teaching, and the responsible
conduct and communication of research. The support of a diverse mentoring team comprised of world experts
in the fields of asthma and psychiatric genetics, metabolomics, integrative omics, and statistics, along with her
strong quantitative training and the vibrant intellectual community of Harvard Medical School and the Brigham
and Women’s Hospital, ensure the success of this proposal. Finally, this research will use state-of-the-art
multiomic techniques to lay the initial groundwork for understanding the pathobiology of asthma and ADHD
comorbidity, a major and well-established public health concern, from which new research programs will emerge.

Public health relevance
PROJECT NARRATIVE Although a rich epidemiological literature has demonstrated a high comorbidity between asthma, the most common respiratory disease worldwide, and attention-deficit/hyperactivity disorder (ADHD), the most common behavioral disorder among children, with reports of significant increases in diagnoses in recent years, no studies have interrogated the potential molecular pathobiology underlying the mutual excess risk between asthma and ADHD. This proposal aims to use integrative techniques by combining genetic and metabolomic data to characterize common and distinct mechanisms and pathways of dysregulated metabolism in the presence of comorbid asthma and ADHD and to develop multiomic profiles which can assist in predicting higher risk of ADHD among asthmatic children. The findings from this study will be instrumental in understanding the molecular underpinnings of two highly prevalent public health concerns, and this study will be the first of its kind to interrogate the molecular intersections between asthma and ADHD.